Preclinical Development of a Novel Therapeutic Agent for Idiopathic Pulmonary Fibrosis

Idiopathic pulmonary fibrosis (IPF) is a progressive interstitial lung disease with a median survival
of only 3 - 5 years from diagnosis. Although two FDA-approved drugs, pirfenidone and nintedanib,
may slow the rate of decline of lung function in some IPF patients, neither drug significantly alters
the course of this lethal disease. There is a great need for new drugs with greater efficacy and
less toxicity for the treatment of patients with IPF. This STTR application addresses the unmet
need for new therapeutic approaches to IPF that would be more effective and less toxic than
current treatments.
Small peptides are widely involved in multiple cellular events and play very important roles in
various cell functions. Interest in peptides as potential drug candidates remains high. With
advances in such fields as chemical synthesis and peptide formulation, peptide drugs - especially
short synthetic and long-acting peptides - are quickly increasing in the global market. The
advantages of small peptides as drugs include their high biological activity, high specificity, and
low toxicity.
FibroBiologics, LLC proposes to develop the novel peptide M10 as an efficacious antifibrotic
therapeutic agent, with a lead indication for the treatment of patients who suffer from IPF. In
Specific Aim 1, we will determine antifibrotic activity of M10 in primary lung fibroblasts isolated
from IPF patients and evaluate an inhibitory effect of M10 on fibrogenic characteristics of IPF lung
fibroblasts. In Specific Aim 2, we will define the efficacious dosing of M10 in two different animal
models of pulmonary fibrosis: bleomycin-induced therapeutic mouse model and FSP-driven
TβR1CA mouse model. The successful completion of these two specific aims will provide
important information about the feasibility of developing M10 as a novel IPF therapeutic and will
justify further studies focusing on gaining FDA clearance, scaling production, and a human clinical
trial.

Public health relevance
Project Narrative In this Phase I STTR, FibroBiologics, LLC will determine antifibrotic activity of a novel antifibrotic peptide M10 in primary lung fibroblasts isolated from IPF patients and prove its feasibility in two different animal models of pulmonary fibrosis: bleomycin-induced and FSP-driven TβR1CA mouse models of pulmonary fibrosis. The impact of the proposed work on public health will be significant, as it will contribute to the development of an effective strategy for the treatment of IPF. Moreover, the M10-based therapeutics developed in our study might be effective in other pathological conditions and diseases characterized by excessive scarring and fibrosis.